Mechanisms that Enhance and Suppress HIV-1 Resistance in Gene Edited Primary Human Cells

While there have been great advances in HIV therapies over the past decades, the only true cure so far has
been through hematopoietic stem cell transplant (HSCT) of cells naturally lacking the HIV co-receptor CCR5.
Due to the toxicity of conditioning regimens prior to HSCT and significant morbidity due to graft-verses-host
disease (GVHD), allogeneic HSCT is not a viable option for most patients. With the advent of CRISPR,
modification of a patient’s own cells to prevent GVHD is now possible, but thus far the efficiency at which cells
have been modified was not enough to prevent viral rebound in the absence of anti-retroviral therapy. In line
with the rationale for combination anti-retroviral drug therapy to target multiple steps in replication, we have
developed a multi-factor knock-out/knock-in strategy for editing CD34+ hematopoietic stem and progenitor
cells which allows greater than 90% deletion of CCR5, as well as up to 50% allelic knock-in of two inhibitory
peptides targeting either fusion (C46V2o) or uncoating (a human-rhesus chimeric TRIM5a). When using this
strategy to edit primary human CD4+ T cells, the efficiency of knock-out/knock-in is sufficient for complete
inhibition of CCR5-tropic virus (BaL), and an average of more than 700-fold inhibition of CXCR4-tropic virus
(NL4-3) when tested across 5 different primary human T cell donors. While these data are extremely
promising, there was a large disparity in the efficiency of inhibition of CXCR4-tropic replication by the human-
rhesus TRIM5a, with some T cell donors showing greater than 1,000-fold inhibition in the hRhTRIM5a knock-
in condition, and some showing little or no significant inhibition of replication. This observation was in spite of
sustained levels of allelic knock-in and hRhTRIM5a RNA expression throughout the course of the infection, and
no resistance mutations observed in the infectious virus at endpoint. We therefor propose here to study the
underlying T-cell/TRIM/virus interactions which may be uniquely donor specific and influence viral replication
including T cell cytokine expression, viral reactivation, and expression of endogenous cellular factors that may
act as a dominant negative to our inhibitory hRhTRIM5a in addition to investigation of other TRIM-related
factors for inhibition such as TRIMCyp. Although the final goal is to develop a therapy through transplantation
of edited hematopoietic stem and progenitor cells, this proposal is entirely based on editing and investigating
the mechanisms of restriction in differentiated primary human target cells such as CD4+ T cells, monocytes,
and macrophages in order to better understand the biology within our editing platform and allow eventual
improvement of the platform. Successful completion of this proposal will allow a better understanding of
mechanisms of restriction in primary cells where often these mechanisms have been predominantly studied in
immortalized cell lines. In addition, completion of this proposal to improve our therapeutic platform will widen
the pool of patients potentially able to be treated using genetically modified autologous HSCT such as patients
later in infection that may have predominantly CXCR4-tropic virus.

Public health relevance
Gene editing allows the potential of HIV patients to be cured by transplantation of a patient’s own blood stem cells after editing by deletion of required factors and addition of factors that inhibit virus replication. While stacking of these inhibitory factors in the primary infected cell, the CD4+ T cell, shows great promise there is a large variability in how efficiently the virus is inhibited. This proposal aims to understand the biology behind the virus and the knock-in factors in relation to human-specific differences in these and other cells relevant for infection in order to improve gene editing therapies.